1/2 Discovery and validation of neuronal enhancers associated with the development of psychiatric disorders

Project Summary/Abstract
This proposal is designed to extend the work of the PsychENCODE Data Analysis Core (DAC)
grant to implement a long term stewardship plan for the data and resources generated both by
the parent grant and the broader PsychENCODE consortium, and continue to support data
coordinating for the PsychENCODE consortium for an additional year. Sage Bionetwork, as the
DCC of the PsychENCODE program over the last 7 years has been responsible for tracking,
curating, distributing of data, methods, and analysis results as well as supporting the DAC through
access to raw data and re-distribution of harmonized datasets. In this role we have built out
processes for collecting and curating data, analytical methods and provided spaces for
collaborative analysis. This effort culminated in the phase I analysis of a harmonized bulk tissue
dataset of genomic, transcriptomic, and epigenomic data from >2000 donor brains resulting in
manuscripts published in a special issue of Science. A similar effort is ongoing in phase II focusing
on single cell data. Combined, the PsychENCODE data corpus is close to 500 terabytes of data
stored in Synapse, an NIH data repository and made available in a custom knowledge portal, the
PsychEncode portal. Here we propose how to transition long term stewardship of this data to the
NIMH data archive (NDA), and support of data from 14 phase II grants with an end date beyond
the March-31 2023 project end of the parent grant.

Public health relevance
Narrative This supplement is aimed at extending the long term stewardship of resources generated by the parent grant and other PsychENCODE grantees. This includes passing the long term stewardship of existing data and resources from the PyschENCODE portal to the NIMH Data Archive. Furthermore, this supplement extends to support the standardization and coordination of data being generated across all remaining PsychENCODE grants.